PHARMACOGENETICS OF NALTREXONE IN ASIAN AMERICANS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To test whether naltrexone reduces sensitivity to the effects of alcohol and alcohol craving among Asian Americans using a controlled alcohol challenge design